Facilitated recruitment of MYC to chromatin by interaction with WDR5

PROJECT SUMMARY
MYC is an oncoprotein transcription factor that features prominently in cancer. As a transcription factor, the
ability of MYC to recognize its target genes is paramount to its activity. The long-standing paradigm for how
MYC selects its targets is that it dimerizes with MAX, forming a module that binds specific DNA sequences
in the regulatory elements of target genes. In recent years, however, it has become clear that target gene
recognition by MYC can also depend on additional chromatin-resident proteins that act through avidity to
direct MYC:MAX dimers to specific sites in the genome. This 'facilitated recruitment' process is poorly
understood, although it likely influences a majority of MYC binding to chromatin in cancer cells. Detailed
mechanistic studies of facilitated recruitment are needed to understand this most basic aspect of MYC
activity, and are timely because, unlike MYC, these recruiters may be amenable to drug discovery,
unlocking new ways to target MYC in the clinic. This project explores the mechanisms and significance of
facilitated recruitment of MYC to chromatin by WDR5, a conserved nuclear protein that is an active target
for drug discovery by numerous groups. WDR5 recruits MYC to chromatin at genes vital for protein
synthesis, including a collection of ribosomal protein genes and genes encoding translation factors and
nucleolar RNAs. Disrupting interaction of MYC with WDR5 in a preexisting malignancy promotes rapid and
irreversible tumor collapse, indicating that the MYC–WDR5 nexus can be pharmacologically inhibited as a
treatment for MYC-driven cancers. Aim 1 of this project uses a combination of high resolution genetic,
genomic, and proteomic approaches to characterize the fundamental mechanisms that bring MYC and
WDR5 together on chromatin, and to reveal the extent to which facilitated recruitment by WDR5—and other
recruiters—determines the genes that are controlled by MYC in cancer cells. Aim 2 blends genetic,
genomic, and in vivo studies to probe the importance of the MYC–WDR5 connection in a diverse set of
cancer contexts, and to reveal precisely how targeting this connection promotes tumor regression. These
studies will lead to a new and robust paradigm for the mechanisms of target gene selection by MYC, identify
novel and targetable vulnerabilities in the MYC network, and show how gene-selective recruiters such as
WDR5 can be exploited to therapeutically inhibit MYC. Importantly, these studies will also lay the biological
groundwork for the implementation of WDR5 inhibitors in the clinic as anti-MYC agents.

Public health relevance
PROJECT NARRATIVE The oncoprotein transcription factor MYC is overexpressed in the majority of cancers and contributes to an estimated 100,000 deaths in the USA each year. This proposal outlines a strategy to define how MYC works with its co-factor WDR5 to drive gene expression changes that establish and maintain the malignant state. Completion of this work will expose unappreciated aspects of the molecular processes that drive cancer and how these can be therapeutically blocked in tumor cells.